The interleukin-1 receptor regulates crosstalk between myeloid and renal tubular cells in hypertension

The World Health Organization estimates that hypertension impacts 40% of the world’s adult population. Despite
the catastrophic cardiovascular complications of hypertension such as stroke, congestive heart failure, and
chronic kidney disease (CKD), blood pressure remains poorly controlled in more than half of patients carrying
the diagnosis 7. The SPRINT trial demonstrated the benefits of tight blood pressure control, highlighting the need
to develop novel agents to further reduce blood pressure and limit target organ damage in hypertension. The
recent recognition that innate immune responses contribute to hypertension and its complications should
facilitate the development of novel immunomodulatory interventions for hypertension. However, disrupting the
pro-hypertensive actions of inflammatory mediators without inducing harmful immunosuppression will require
elucidation of the discrete cell-specific mechanisms through which innate immune responses drive blood
pressure elevation and consequent end organ injury. Circulating monocytes and tissue macrophages are key
effectors of innate immunity, and interleukin-1 (IL-1) is the prototypical cytokine produced by pro-inflammatory
macrophages. We have found in a murine hypertension model that genetic deletion or pharmacologic blockade
of the receptor for IL-1 (IL-1R1) enhances urinary excretion of nitric oxide (NO), attenuates renal sodium
retention, inhibits the NKCC2 transporter, and limits blood pressure elevation. We therefore hypothesize that
IL-1 receptor activation on kidney epithelial cells suppresses their generation of NO and thereby promotes
sodium reabsorption in the nephron. To test this hypothesis, we will examine renal sodium transport, NO
generation, and susceptibility to hypertension in a murine model of nephron-specific IL-1R1 deficiency (IL-1R
KKO). Treating these animals with angiotension receptor blockade (ARB) and diuretics will identify additive
clinical benefits of abrogating IL-1R1 signals in kidney epithelial cells and elucidate downstream mechanisms
through which the IL-1R in the nephron raises blood pressure. Uncontrolled hypertension and other causes of
CKD culminate in irreversible kidney fibrosis. NO can also attenuate renal fibrosis, and our new preliminary data
suggest that myeloid cell-specific deletion of IL-1R mitigates ischemic damage that drives renal fibrogenesis. We
therefore posit that IL-1R1 activation in intra-renal macrophages attenuates their generation of NO and
exacerbates kidney fibrosis. We will directly test the contribution of IL-1R1 in macrophages to kidney fibrogenesis
by genetically excising IL-1R1 from myeloid cells in mice (IL-1R KKO) and subjecting these animals to insults
that trigger renal fibrosis. With this stepwise approach, we will discover complementary, cell-specific actions of
IL-1R1-dependent blood pressure regulation and kidney damage that can underpin the development of novel
immunomodulatory therapies for hypertension.

Public health relevance
Hypertension impacts 30% of adults in the United States and leads to severe cardiovascular complications including stroke, congestive heart failure, and end-stage kidney disease. The current proposal will elucidate mechanisms through which myeloid cells interact with kidney tubular cells to regulate salt transport in the kidney during hypertension and provoke inflammation leading to renal scar formation. Knowledge of these mechanisms will allow the design of potent immune-directed therapies to more effectively lower blood pressure and limit target organ damage in hypertension.